USC COMPREHENSIVE CAN CTR (CORE) SUPPORT

The Kenneth Norris Jr. comprehensive Cancer Center at the University of Southern California has been in existence since mid-1971 and continuously supported by a Cancer Center (Core) Support Grant since 1973. In the intervening years, the Center has developed to a major regional resource for cancer research, treatment, prevention and education. Center facilities have been built and developed with support from the NCI, the University, and, in its early days, the County of Los Angeles. Research is organized into six program areas, each headed by two senior investigators: Gene Regulation; Tumor Biology; lmmunobiology, Pathogenesis and Treatment; Developmental Therapeutics; Cancer Etiology; and Cancer Prevention Research and Education. In this application we are requesting the following: 1. partial salary support for the Center's senior leadership who are responsible for planning and overseeing our research efforts; 2. partial salary support for selected staff investigators who qualify according to NCI guidelines; 3. support for planning and evaluation to keep the Center at the forefront of cancer research; 4. support for the administrative infrastructure of the Center; 5. partial support for the Center's shared resources and the development of one new facility; 6. and support for developmental funds to help us recruit new investigators in the areas we have targeted for expansion. Continued funding from the Cancer Center (Core) Support Grant program will allow us build on and expand our strengths and to develop initiatives in promising areas of cancer research, treatment, prevention and education.